G-PROTEIN FUNCTION IN PLANT HORMONE TRANSPORT

DESCRIPTION (Adapted from the applicant's abstract): G-proteins are crucial components of the transmembrane signalling chains of several animal cell membrane receptor systems, coupling the receptors to effectors that are often either enzymes or ion channels. G-proteins have been discovered in plant cells that have many of the characteristics of animal G-proteins and are recognized by animal G-protein-specific antibodies. These G-proteins, from stem cells in zucchini seedlings, interact with carrier proteins in the cells' plasma membranes that function to move the plant hormone auxin in and out of the cell across the membrane. The G-proteins also interact with the receptor for a powerful inhibitor of that auxin movement, naphthylphthalamic acid (NPA). The long-term objective of this application is to understand the role played by these plant G-proteins in the carrier-mediated uptake and efflux of auxin in plant cells, and the regulation thereof by NPA. It is likely that the information obtained about intramembrane transporters (the auxin carrier) will advance the understanding of G-protein function in general, and thus advance the health sciences in a direct way. The planned research will: (a) Fully characterize the GTP binding proteins of zucchini stem tissue. The techniques of ligand-receptor binding assays will be used to examine guanine nucleotide binding kinetics and the effects of the G-proteins on NPA binding to its receptor. Density gradient fractionation of stem cell membranes coupled with guanine nucleotide binding assays will help localize the G-proteins within the cell, as will immunofluorescent labeling of stem tissue slices using G-protein-specific antibodies. (b) Test the physiological relevance of the GTP binding proteins. A number of useful tools (nonhydrolyzable analogs of GTP, cholera and pertussis toxin, specific antibodies) that indicate the involvement of G-proteins in animal systems will be utilized to test that involvement in auxin transport in cells and tissues. Purified G-proteins will be incorporated into reconstituted artificial membrane vesicles with NPA receptors and auxin carriers to test for reconstituted NPA regulatory function; standard assays for auxin accumulation by stem cells and plasma membrane vesicles, and for polar auxin transport in stem tissue, will be employed. (c) Use molecular techniques to: (i) elucidate the evolutionary relationship between G-proteins from different plant species and between plants and animals, and (ii) probe the tissue specificity of the plant G-proteins, and the timing of their developmental appearance to test the relationship between their presence and a functioning auxin transport system.